PHASE III--TILURONATE DISODIUM IN TREATING PAGET'S DISEASE

The purpose of this study is to evaluate the efficacy of Tiludronate disodium at two doses compared to placebo on total serum alkaline phosphatase activity of subjects with Paget's disease.